Pilot Core (AD/ADRD Focus): Technology Development and Refinement

PROJECT SUMMARY/ABSTRACT
The goal of Pilot Core (PCA) for Alzheimer's disease/Alzheimer's disease related dementias (AD/ADRD) is to
take a multidisciplinary collaborative approach to identify, develop, refine, and disseminate promising
technologies that have high potential to improve the health and wellbeing of older Americans living with
AD/ADRD and/or their caregivers, with an emphasis on those that can mitigate current disparities in access
and delivery of dementia care in the US and globally. Specific aims are to: (1) develop a national call and fund
pilot projects focused on the application of AI and machine learning-supported technologies to improve the
health and well-being of older adults with AD/ADRD and/or their caregivers; (2) ensure pilot projects are well-
designed, timely and rigorous by providing intellectual leadership, oversight, and access to all of the AITC
resources; (3) assist in the further development and translation of completed pilot projects into products that
will benefit older adults with AD/ADRD and/or their caregivers; and (4) expand the expertise and network of
funded investigators focused on advancing dementia - related AI technologies.
Pilot projects will use Artificial Intelligence (AI) approaches and technologies to broadly address four key
research domains: Person Living with Dementia Care and Engagement; Diagnostics and Assessment; System
Management and Administration; and Caregiver and Workforce Support. Projects will be consistent with the
overall themes of this AITC and NIA's AD+ADRD Research Implementation Milestones. Projects will use a
range of new technologies, adaptations, and/or integration of multiple technologies to address issues within
these major domains. These include, but are not limited to, big data analytics, natural language processing,
mobile/cloud/smart device technologies, robotics, image and biometrics, digital biomarkers, imaging, and
integrated platforms that can host and integrate multiple technologies (e.g. electronic health records combined
with administrative and sensed data).
The Core features an ambitious research agenda that features a well-qualified, visionary, and multidisciplinary
team to advance dementia care quality, access, and delivery through harnessing the potential of new AI,
machine learning and other technologies. Our goal is to produce products that address the multifactorial
determinants of health and well-being and that can transform care “on the ground” for older adults living with
AD/ADRD and their caregivers.